DNMT3A in Development of Hematologic Malignancies

Project Summary/Abstract
Cancers of the hematopoietic system, including leukemias and lymphomas, make up over 7% of new cancer
diagnoses identified every year. While some types are increasingly treatable, others, such as acute myeloid
leukemia, have a poor long-term survival rate. Recent studies have shown that initiating mutations often occur
in hematopoietic stem cells (HSCs), resulting in a pre-malignant clone that can survive and expand for decades
before additional hits drive exponential growth. For improved treatment of hematologic malignancies, it is
imperative to understand the initiating mutations, how they drive pre-malignant expansion, how they promote
transformation in the context of additional mutations, and to develop strategies to eradicate pre-malignant clones.
The proposed program aims to address some of these questions, focusing on the role of mutations in the critical
tumor suppressor DNMT3A. DNMT3A is important for normal stem cell differentiation and its deficiency
cooperates with numerous other mutations to drive a variety of hematologic malignancies. Here, we will
particularly focus on how DNMT3A mutations cooperate with a common co-mutation in nucleophosmin 1
(NPM1). Our previous work showed that the oncogenic cytoplasmic variant, NPM1c, drives gene expression at
the critical HOXA locus. Here, using mouse models, human cell lines, and leukemia samples, we examine how
DNMT3A loss potentiates the activity of NPM1c by modulating chromatin. We will also examine in depth the
mechanisms of pathogenesis of NPMc by identifying its localization on chromatin, domains required for nuclear
condensate formation, and protein and nucleic acid interacting partners. Finally, we will investigate the role of
the ubiquitin-degradation complex adaptor protein DCAF8 in modulating DNMT3A in vivo with a view to potential
therapeutic applications. We have established a battery of reagents and technologies including novel mouse
models to facilitate this program. The program addresses questions designed to uncover fundamental biology
with a view to developing new therapeutic approaches in the long-term. Given our long track-record in this area,
we are poised to continue to make significant contributions to this critical area of cancer biology. The principles
we uncover here may be applicable to other epigenetic regulators in a variety of malignancies.

Public health relevance
Narrative Cancers of the blood are often initiated by a mutation in a gene called DNMT3A that normally prevents malignancies. In this program we seek to understand how this mutant protein can powerfully collaborate with many other cancer-causing genes to promote malignancies, in order to develop new therapeutic strategies in the long-term.